Tailored Mobile Text Messaging to Reduce Problem Drinking

DESCRIPTION (provided by applicant): This application is submitted in response to NIAAA's program announcement, Behavioral & Integrative Treatment Development Program, PA-10-013 and is consistent with NIH's recent interest in developing adaptive mobile interventions. The proposed development study entitled, Tailored Mobile Text Messaging to Reduce Problem Drinking is designed to develop and test a tailored adaptive text messaging/short message service (SMS) intervention for individuals interested in stopping or reducing their alcool consumption. Excessive alcohol consumption is a serious personal and public health issue and economic problem to society. Despite the significant consequences of problem drinking (PD), most persons with alcohol problems never seek formal treatment. While the emergence of internet based interventions (IBIs) has expanded access and brief intervention opportunities to problem drinkers, traditional IBIs suffer from high attrition, limited ability to proactively meet individuals where PD occurs and adapt to real-time needs. Recent evidence from smoking cessation studies highlight that SMS interventions may provide the needed reinforcement to help individuals enhance self-regulation and reduce problem alcohol use when they need it most in their natural environment. Moreover, because PD typically has regular episodic patterns, tailored interactive designs may be particularly effective. This study is designed to develop and test an interactive adaptive mobile messaging intervention for PD, which includes messages tailored to baseline assessment results (including drinking times) that are adaptive to ongoing drinking patterns and goal achievement via interactive ecological momentary assessment (EMA). Other features include participant initiated help messaging and support network alerts. We will conduct beta research with 40 problem drinkers to assess messaging preferences and acceptability, and then conduct a pilot test with 10 PDs. In Stage 1b, we aim to test this intervention and understand the mechanisms of action of different text messaging interventions with 200 problem drinkers over a 12-week period. We propose to compare four types of messaging: 1) Tailored content and timed messaging adaptive to the participants current state (Stage 1a intervention)~ 2) Tailored content messaging (not adaptive or timed) sent at 3 pm every day~ 3) Untailored consequence based messages sent at 3 pm every day~ and 4) Brief feedback and EMA only. Assessments will be completed at baseline, through weekly EMA via SMS and at week 12 via a web-based follow-up assessment. Primary outcomes include drinks per drinking day, days of heavy drinking, and average drinks per week as measured through weekly EMA. Additional outcomes will include drinking related consequences, goal commitment and intervention satisfaction. Outcomes will be used to modify the intervention and to prepare for a larger Stage 1c RCT.

Public health relevance
PUBLIC HEALTH RELEVANCE: Excessive alcohol consumption has serious personal and public health consequences. Internet based interventions for problem drinking have proven mildly effective but have limited ability to help individuals maintain changes. Tex messaging interventions can support individuals proactively and be tailored to an individual's current state with real-time interactive features. We propose to create an adaptive tex messaging intervention to reduce alcohol consumption and related problems and test whether tailored adaptive messaging is superior to untailored messaging in a randomized controlled trial. This intervention could be easily disseminated and potentially improve long-term psychosocial and health outcomes for problem drinkers. __SpecificAimsTextDelimiter__ Specific Aims This application is submitted in response to NIAAA's program announcement, Behavioral & Integrative Treatment Development Program, PA-10-013 and is consistent with NIHs recent interest in developing adaptive mobile interventions. The proposed development study entitled, Tailored Mobile Text Messaging to Reduce Problem Drinking is designed to develop and test a tailored adaptive text messaging/short message service (SMS) intervention for individuals interested in stopping or reducing their alcohol consumption. Excessive alcohol consumption is a serious personal and public health issue and economic problem to society. Despite the significant consequences of problem drinking (PD), most persons with alcohol problems never seek formal treatment. Over the past 10 years there has been an explosive growth in internet based interventions (IBI) sites for problem drinking with promising evidence. They can reach the large group of individuals who do not want formal treatment for problem drinking but would like guidance on change options in the privacy of their own homes. However, IBIs have several short-comings including high attrition, inability to proactively catch people in their environment where and when problem drinking occurs, and limited ability for ongoing tailoring based on changes in drinking symptoms. Mobile based interventions can resolve many of these limitations. Between 86- 91% of the US population over 18 has a mobile phone with equal distributions across races and ethnicities and between 90-98% of all mobile phones are SMS capable. SMS interventions have been examined across a number of problems and diseases with the greatest efficacy being found for tobacco cessation and weight loss. While no studies have examined SMS interventions with PD, one study using preprogrammed personal digital assistants offering tailored messages on the consequences of excessive drinking reduced drinks per drinking day in non-treatment seeking college students compared to an assessment only control highlighting the potential use of SMS with PD. SMS interventions for PD can push content proactively for indefinite periods following a one-time user initiation, can be received and responded to anytime and anywhere there is cell phone reception, can be tailored to an individual's current state with real-time interactive features (e.g. during high craving or heavy drinking periods) which can stimulate memory of change goals in high risk situations and promote self-regulation when individuals need it most. Despite the new growth of SMS interventions and early promising studies in other areas, there have been no published SMS studies with problem drinkers looking to change their drinking, and to our knowledge there have been no SMS studies across any health problem or disorder that have directly compared tailored vs. untailored messaging and the effects of dynamically timed-interactive vs. statically timed messaging on outcomes. As a recent NIH review of mobile health interventions highlights, we need to test new behavior change models with the advent of mobile technologies and incorporate the adaptive capabilities into our treatments (Riley, Rivera et al., 2011). Our previous work on the feasibility of using text messages with disenfranchised individuals in addiction treatment revealed that 98% are interested in using SMS to help them stay drug free and that individuals preferred different types of messaging at different periods of recovery. Based on this foundation, we aim to develop an SMS intervention for problem drinkers and to understand the mechanisms of action of text messaging interventions for 200 hundred problem drinkers who complete an online assessment and brief PD one page feedback session. In addition to the brief one page feedback, we propose to compare four types of messaging arms over a 12 week period: 1) tailored content and timed messaging (e.g.. highlight individual goals during normal drinking times) adaptive to the participants current state (Tailored-adaptive)~ 2) Tailored content messaging sent at 3pm everyday (Tailored-only)~ and 3) untailored consequence based messages sent at 3pm everyday (Consequence messaging)~ 4) Assessment only via EMA (Assessment only/EMA). Measurements will take place at baseline, through weekly EMA via SMS, and at Week-12. The aims of this proposal are consistent with the initial sub-stages of Stage I developmental research described in the Stage Model of Behavioral Research (Rounsaville, Carroll & Onken, 2001). Primary Aim 1: To develop an adaptive text messaging program for problem drinking. 1A. Develop a brief assessment, normative feedback and list of text messages based on the PD intervention literature & obtain outside review from thought leaders. 1B. Survey 40 problem drinkers on overall SMS intervention preferences including message content and timing and frequency preferences. 1C. Develop SMS intervention, review with thought leaders and pre-pilot and test with 10 problem drinkers and modify intervention based on feedback. Primary Aim 2: : To test whether the Tailored-adaptive treatment arm is superior to the content tailored only arm and the consequence messaging arm in reducing drinks per drinking day and percent days heavy drinking over the course of the 12 week intervention. Hypothesis 2a: Tailored-adaptive arm will be superior to the content tailored only and consequence messaging study arms in reducing drinks per drinking day. Hypothesis 2b: Tailored-only messaging will be superior to consequence messaging in reducing drinks per drinking day. Hypothesis 2c: All supportive messaging arms will be superior to assessment only in reducing drinks per drinking day.